Systematic identification and interpretation of repetitive variants underlying schizophrenia

PROJECT SUMMARY Schizophrenia is a heritable psychiatric disease affecting approximately 1% of the population. The disease is associated with high morbidity and mortality and is a leading cause of disability. Genome­wide association studies (GWAS) have identified >100 genetic loci associated with schizophrenia. However standard GWAS are largely limited to detecting simple point mutations, or single nucleotide polymorphisms (SNPs), consisting of single base pair substitutions. Thus, GWAS is unable to capture complex variants such as copy number variants (CNVs) and tandem repeats (TRs) that are not well tagged by SNPs. Multiple lines of evidence support the hypothesis that TRs play a role in psychiatric disease. TRs are one of the largest sources of genetic variation, are weakly tagged by SNPs, and play a significant role in regulating gene expression and splicing. Intriguingly, >30 Mendelian disorders are caused by TR expansions. Nearly all repeat disorders involve neurological phenotypes, many have psychiatric components, and some implicated genes have also been identified in schizophrenia GWAS. I hypothesize that tandem repeats play a significant role in schizophrenia risk and drive a subset of GWAS signals. I propose to develop an array of computational techniques to integrate TRs into psychiatric and other GWAS. In Aim 1 we will develop algorithms to accurately genotype long TR polymorphisms in large next­generation sequencing cohorts. In Aim 2 we will generate a high quality reference haplotype panel for a targeted set of TRs using traditional family­based phasing methods combined with long range phasing from novel single­molecule sequencing technologies. In Aim 3 we will deeply characterize medically relevant TRs in psychiatric disease by imputing TRs into large existing GWAS cohorts. Finally, in Aim 4 we will develop a novel haplotype test capturing genome­wide TR associations from existing GWAS datasets. Taken together, these innovations will provide a powerful framework for interrogating the role of TRs in human disease. Genome­wide scans for association (Aim 4) can be combined with targeted methods of Aims 1­3 for genotyping or imputing TRs, fine mapping against other variant types, and performing functional follow up. Technologies for high throughput TR genotyping and imputation will revolutionize our ability to discover disease­associated TRs and enable unprecedented study of TRs in broad applications including GWAS, Mendelian genetics, and cancer.

Public health relevance
PROJECT NARRATIVE Schizophrenia is a heritable psychiatric disease affecting approximately 1% of the population. While great progress has been made in identifying genetic changes leading to schizophrenia and other common diseases, variations at repetitive DNA have largely been ignored due to the bioinformatic challenges they present. This project investigates the contribution of genetic variation at repetitive DNA to schizophrenia risk by developing novel computational methods that will allow broad integration of repetitive DNA analysis into genome wide studies.